Intracellular Signaling by Bacterial Chemoreceptors

Project Summary
Chemotactic behaviors, movements toward or away from chemicals in an organism’s environment, play
important roles in the lives of bacteria. Chemotaxis enables microbes to form communities such as
biofilms, to find and colonize host organisms, and to successfully carry out complex, multi-host life
cycles. Better understanding of how bacteria detect and respond to their chemical environment will
play an important role in the development of new therapeutic strategies for preventing and treating
bacterial infections. The long-term goal of this project is to elucidate, in molecular detail, the in vivo
signaling mechanisms of the transmembrane receptors that mediate chemotactic behavior in E. coli, a
model system for chemotaxis studies.
The serine chemoreceptor Tsr forms stable ternary complexes with two cytoplasmic proteins: CheA, a
histidine autokinase, and CheW, which couples CheA to chemoreceptor control. These complexes are
organized into highly cooperative arrays, typically located at the cell poles, that produce most of the
prodigious signal amplification known to occur in the E. coli chemotaxis pathway. The overall
objectives of the next project period are to elucidate the mechanisms involved in three signaling
processes: signal transmission within chemoreceptor molecules and allosteric control and kinase
control in core receptor signaling complexes.
Our overall working hypothesis about signal transmission within chemoreceptor molecules proposes
that its structural subelements – external ligand-binding domain, transmembrane helices, HAMP and
methylation helix bundles, and cytoplasmic hairpin tip that interacts directly with CheW and CheA –
transmit and process sensory information through shifts in their dynamic behaviors and stabilities.
Neighboring elements are coupled in opposition, such that destabilizing inputs to one element produce
stabilizing responses in the other. The interplay of these opposing structural forces poises the receptor
molecule to detect and respond to small stimulus inputs.
The project will test these signaling ideas by mutationally creating structural changes in Tsr, CheA, and
CheW and characterizing their signaling consequences with in vivo serine dose-response assays
based on Förster Resonance Energy Transfer (FRET). Collaborations with other groups will provide
molecular dynamics simulations to assess the structural and dynamics changes in the mutant proteins,
single-cell FRET analyses of receptor responses, homo-FRET studies of receptor response kinetics,
and cryo-electron microscopy to examine structural features of the mutant receptor arrays.

Public health relevance
Project Narrative Chemotactic behaviors influence the environmental distributions of motile microorganisms, the composition of microbial communities such as biofilms, and host invasion during the establishment of beneficial symbioses and harmful infections. Better understanding of the molecular mechanisms of stimulus detection and sensory signaling by bacterial chemoreceptors should lead to new strategies for augmenting the beneficial behaviors of bacteria and to new therapies for harmful bacterial infections.